Effects of Artemin on Nociceptors

DESCRIPTION (provided by applicant): The long-term objective of this study is to determine how the growth factor artemin (Artn) causes thermal and chemical sensitization of sensory neurons under conditions of chronic inflammation. Artn expression is normally low but becomes significantly elevated in inflamed tissue. Mice that overexpress Artn in skin (ART-OE mice) or that are injected with Artn also exhibit behavioral sensitivity to heat, cold and chemical (capsaicin and mustard oil) stimuli. The ability of Artn to induce thermal and chemical sensitivity and its rise in inflamed tissue suggests that Artn signaling underlies a component of the hypersensitivity associated with inflammation. Analysis of sensory ganglia of ART-OE mice showed enhanced expression of TRPV1 and TRPA1 suggesting the activity of these channel receptors underlie at least some of the Artn-induced sensitization. However, new microarray profiling data of ART-OE ganglia showed a significant elevation in subunits of the nicotinic acetylcholine receptor (nAChR), suggesting Artn modulates the composition of nAChRs as well. We therefore propose to test the hypothesis that the thermal and chemical sensitivity exhibited by Artn-responsive GFR13-positive afferents reflects not only enhanced TRP responses but also enhanced activity of nAChRs. We propose three specific aims: Aim 1 will use immunodetection assays to assess how Artn and inflammation affects translation and distribution of nAChR subunits in sensory afferents. Aim 2 uses calcium imaging and patch-clamp protocols to determine the effect of Artn on functional properties of nAChRs in GFR13 afferents under normal and inflamed conditions. Aim 3 will determine whether nAChR subunits contribute to inflammatory thermal hyperalgesia using a newly developed siRNA procedure that will reduce expression of specific nAChR subunits in peripheral neurons. In vivo assays will be used to determine if hypersensitivity induced by CFA injection can be reduced. These findings of Artn regulation of nAChR expression provide a new dimension for investigating the role of growth factors in sensory afferents and their role in the pathogenesis of inflammatory disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Local, non-neuronal production of neuro-active substances such as growth factors, acetylcholine, glutamate and peptides is commonly elevated in inflammatory diseases such as pancreatitis, psoriasis, rheumatoid arthritis and cystitis. Our findings suggest that the growth factor Artn is produced in inflamed tissue and that its production contributes to sensitization of a specific subpopulation of pain signaling neurons. We propose a mechanism by which Artn produces its effect that, if correct, may allow development of analgesic compounds that are effective in treating pain associated with chronic inflammatory disease. Relevance of the proposed studies. Local, non-neuronal production of neuro-active substances such as growth factors, acetylcholine, glutamate and peptides is commonly elevated in inflammatory diseases such as pancreatitis, psoriasis, rheumatoid arthritis and cystitis. Our findings suggest that the growth factor Artn is produced in inflamed tissue and that its production contributes to sensitization of a specific subpopulation of pain signaling neurons. We propose a mechanism by which Artn produces its effect that if correct, may allow development of analgesic compounds that are effective in treating pain associated with chronic inflammatory disease. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The goal of this study is to understand how the growth factor artemin (Artn) causes thermal and chemical sensitization of sensory afferents under conditions of chronic tissue inflammation. In humans and mice, Artn expression is significantly elevated in inflamed tissue [7, 58], even more so than nerve growth factor (NGF), a known mediator of inflammatory pain. Transgenic mice that overexpress Artn in the skin (ART-OE mice) also exhibit behavioral sensitivity to heat, noxious cold, and chemical (capsaicin and mustard oil) stimuli [19, 20]. In addition, a single injection of Artn in skin of wildtype (WT) mice causes short-term (24h) heat hyperalgesia that is prolonged to 7 days if Artn is coinjected with NGF. The ability of Artn to cause thermal and chemical sensitivity, its synergistic action with NGF, and its rise in inflamed tissue suggests that Artn-induced afferent sensitization underlies an important mechanistic component of pain associated with inflammatory disease. One clue to the mechanisms underlying Artn sensitization was provided by analysis of ion channel expression in trigeminal ganglia (TG) and dorsal root ganglia (DRG) of ART-OE mice. Neurons that express the Artn receptor GFRα3 had enhanced expression of the transient receptor potential channels, TRPV1, and TRPA1. In addition, sensory neurons from ART-OE mice or WT DRG neurons acutely exposed to Artn exhibit reduced heat thresholds and enhanced Ca2+ transients in response to the TRPV1 agonist capsaicin (CAP) [20, 58, 89]. Although the increased TRP expression is likely to underlie some of the Artn-induced sensitization, new insight into the complexity of Artn signaling was obtained by microarray expression profiling of ART-OE ganglia. This analysis showed a significant elevation in specific subunits (α3, β3, and β4) of the nicotinic acetylcholine receptor (nAChR) family, suggesting Artn signaling modulates the composition and, thereby the properties, of nAChRs in GFRα3-positive nociceptors. In support of this possibility, expression analysis of ganglia from mice that lack Artn or GFRα3 show reduction in nAChR subunit mRNAs. In addition, we found that: 1) nAChR α3β4 transcripts are increased in DRG from mice treated with complete Freund's adjuvant (CFA), which is known to increase Artn expression in the skin [58] 2) treatment with nAChR antagonists (mecamylamine or hexamethonium) blocks Artn-induced thermal hyperalgesia; 3) nicotine (NIC) potentiates K+-induced Ca2+ influx in DRG neurons; and 4) Artn increases NIC-evoked Ca2+ transients in DRG neurons. These findings suggest nAChR activation in the periphery directly contributes to afferent excitability and leads to the hypothesis that the Artn-induced thermal and chemical sensitivity exhibited by GFRα3-positive neurons reflects not only enhanced TRP responses but also enhanced activity of nAChRs composed of α3β3β4 subunits. To better understand the functional consequences of Artn signaling and to test the role of nAChRs in GFRα3 afferent sensitization, we propose the following Aims: Aim 1. Determine the effect of increased Artn on expression and spatial distribution of nAChRs. We found a significant increase in mRNAs encoding the nAChR subunits α3, β3, and β4 occurs in DRG of ART-OE mice and CFA-injected WT mice. To determine if this increased expression is restricted to GFRα3 neurons, immunolocalization assays will be done on DRG of WT, ART-OE, and CFA-treated mice. Immunoblot analysis of ganglia, dorsal lumbar spinal cord, and peripheral nerves will also be done to quantify and localize expression of α3/β3/β4 subunits in the DRG, dorsal horn (DH), and peripheral nerve compartments. Aim 2. Determine the effect of Artn on the functional properties of nAChRs in GFRα3-positive afferents. To determine the basis for the Artn-induced sensitization of NIC evoked responses, Ca2+ imaging and patch clamp analysis combined with single-cell RT-PCR will be used to define the magnitude of effect and determine if enhanced nAChR responses are restricted to GFRα3 neurons. Comparative analysis of identified cutaneous afferents isolated from WT mice and mice with CFA-induced inflammation of the foot will be done. Aim 3. Use in vivo RNAi delivery to determine if α3/β3/β4 nAChR subunits contribute to inflammatory thermal hyperalgesia. If signaling via nAChRs containing α3β3β4 subunits contributes to Artn-induced GFRα3-afferent sensitivity, a prediction is that reduction of individual subunits will decrease the behavioral thermal sensitivity displayed by mice with CFA footpad injections. We will use a newly developed siRNA knockdown procedure that restricts gene knockdown to peripheral neurons to reduce expression of nAChR subunits. At times following CFA injection, the effect of subunit knockdown on RNA and protein expression, nAChR-evoked responses, and behavioral sensitivity will be measured. The proposed experiments investigate a newly identified linkage between Artn, sensitization and nAChR expression in GFRα3 nociceptors. These data will expand our understanding of how growth factors promote primary afferent sensitization in chronic, painful conditions. These findings may also contribute to design of new therapeutic approaches to pain management that incorporate selective modulation of nAChRs and/or Artn signaling.